RETROSPECTIVE STUDY OF CLINICALLY ASCERTAINED CASES

The National Institute of Child Health and Human Development (NICHD) has need for the services of the Foundation for Blood Research (FBR) to perform a retrospective study of 100 clinically ascertained cases of Smith-Lemli-Opitz Syndrome (SLOS), confirmed by 7-DHC testing, and obtain triple marker screening results done on the mothers of S patients.